Stem Cells and Regeneration

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Stem Cells and Regeneration, organized by
Drs. Heinrich Jasper and Emmanuelle Passegué. The conference will be held in Santa Fe, New Mexico from
January 22–25, 2024.
Regenerative medicine relies on a deep mechanistic understanding of tissue stem cell biology and innovative
approaches to reprogram cells and tissues. This Keystone Symposia conference brings together leading
researchers who study the biology of tissue stem cells and tissue regeneration and who have employed this
knowledge to develop therapeutic applications in regenerative medicine. The program of the meeting explores
these processes across diverse tissue types, and thus encompasses stem cell populations and regenerative
pathways across biological systems, ranging from hematopoietic stem cells to vascular systems to the retina. A
particular focus will be on promoting tissue regeneration even in the absence of endogenous stem cells (as in
the retina) as well as on rejuvenation approaches based on in vivo partial reprogramming. This conference will
run in parallel with our recurring Keystone Symposia meeting on Emerging Cellular Therapies and will feature
two joint scientific sessions that explore cellular approaches in regenerative medicine and gene therapy
applications. It is anticipated that facilitating interactions beween speakers and attendees of these two programs
will foster new and synergistic collaborations as well as catalyze new ventures to develop and exploit
regenerative strategies for therapeutic benefit.

Public health relevance
PROJECT NARRATIVE Advances in our understanding of stem cell biology, combined with techniques for engineering diverse cell types with useful and controllable properties, are central to the field of regenerative medicine. This Keystone Symposia conference brings together an interdisciplinary group of researchers from academia and industry to advance the frontiers of research on rejuvenation of tissues and organ systems, with an emphasis on cellular engineering approaches and applications in gene therapy.